GROWTH HORMONE TREATMENT OF CHILDREN WITH INTRAUTERINE GROWTH RETARDATION

Demonstrate high dose GH therapy in IUGR. Further examine any discrepancy between the growth promoting effect and the other metabolic effects of high dose hGH.